12th Annual Conference on the Science of Dissemination and Implementation; POP 8/14/2019-9/30/2019

Support to the NCI for the 12th Annual Conference on the Science of Dissemination and Implementation